Louisiana Pregnancy Risk Assessment Monitoring System Application

CDC-RFA-DP-21-001 Louisiana PRAMS Application
Project Introduction:
The Louisiana Pregnancy Risk Assessment Monitoring System (PRAMS) performs a key
role in evaluating and guiding the Louisiana Bureau of Family Health’s (BFH) efforts through
data analysis and translation in order to reduce infant morbidity and mortality by impacting
maternal behaviors before and during pregnancy and in early infancy. The Louisiana Department
of Health (LDH), Office of Public Health (OPH), Bureau of Family Health (BFH) has
successfully collaborated with the Centers for Disease Control and Prevention (CDC) on
PRAMS as a grantee since 2001. Since then, Louisiana PRAMS data have been used by program
planners, healthcare providers, policy makers, and public health leaders to design, implement and
evaluate programs and services relevant to women and infants in Louisiana. This funding
opportunity will allow Louisiana to continue to provide valuable and unique data to stakeholders.
Prevalence of behaviors and risk factors during the perinatal period can illuminate strategies for
action, and ultimately improve health across the life course for women and infants. This aim is
accomplished through monitoring health status and progress in addressing Health Resources and
Services Administration (HRSA) Title V Maternal and Child Health (MCH) Block Grant 5-Year
Priority Needs and through the following objectives:
 To implement population-based surveillance within a defined vital records jurisdiction on
selected maternal behaviors and experiences that occur prior to, during, and shortly after
pregnancy among women with a recent live birth, including emerging issues, i.e. opioid
use and post-disaster surveillance needs, as they arise.
 To ensure data are of high scientific quality and comparable to other jurisdictions by
following the methodology documented in the CDC PRAMS protocol.
 To conduct comprehensive analyses of PRAMS data based on a written jurisdiction-
specific analysis plan designed to inform programmatic activities, research, and public
health practice.
 To translate and disseminate analytic results into useable information for public health
action that can guide program development and evaluation in collaboration with a
jurisdiction-level steering committee.
Monitoring is performed through data collection and analysis of MCH indicators such as
prenatal care visit access and content, tobacco and alcohol use, breastfeeding practices, oral
health during pregnancy, partner violence, stressful life events, infant sleep position, maternal
depression, pre-pregnancy weight, insurance coverage, and birth outcomes. Louisiana PRAMS
findings and data, which are linked to Louisiana's birth data, are used both internally and
externally to impact public health practice, program implementation and evaluation, legislation
and policy.
1

Public health relevance
CDC-RFA-DP-21-001 Louisiana PRAMS Application Project Narrative: Louisiana Pregnancy Risk Assessment Monitoring System (PRAMS) is an ongoing, population-based risk factor surveillance system designed to describe maternal behaviors and experiences that occur before, during, and immediately following pregnancy. The program is administered by the Louisiana Department of Health, Bureau of Family Health in conjunction with the Centers for Disease Control and Prevention (CDC). Information collected by Louisiana PRAMS is used by health professionals, policy makers, and researchers to develop and modify programs and policies designed to improve the health of mothers and infants. Louisiana PRAMS provides both quantitative and qualitative data on:  Factors that influence pregnancy outcomes, including health insurance status, chronic conditions, pregnancy intention, contraceptive use, prenatal care, alcohol use, tobacco use, physical abuse, and life stress  Mothers’ experience of pregnancy complications, including hypertension, diabetes and hospitalizations  Maternal experiences and behaviors after the baby is born, including depression, maternity leave experiences, breastfeeding, contraceptive use, tobacco and alcohol use, and safe infant sleep practices 1